Acquisition of a laser microtomy system for hard tissue histology

The goal of this project is to extend and enhance the capabilities of multiple NIH funded
researchers in the histologic preparation of undecalcified, plastic-embedded tissue samples. We
are requesting support to purchase TissueSurgeon, to our knowledge the only commercially
available laser microtomy system for preparation of histology slides from tissues containing
mineralized extracellular matrix such as bone and teeth without decalcification. This will be the
second installation of a laser microtomy system at an academic center in North America. The
equipment performs non-contact sectioning of plastic embedded hard tissues. Samples up to 40
mm in width can be processed to produce sections as thin as 10 µm. The method is suitable for
preparing samples for histology, dynamic histomorphometry, immunohistochemistry and other
applications such as Raman imaging, Fourier-transform infrared imaging, backscatter scanning
electron microscopy and nanoindentation. Laser microtomy avoids limitations of current
methods, including the frequent presence of artifacts and very slow throughput. Thus, the
instrument will enhance the health-related goals of the initial user groups which focus on bone
growth and regeneration, bone diseases and remodeling, osteoarthritis, tissue engineering and
dental reconstruction. Taking advantage of the Rush MicroCT/Histology Core, where the
instrument will be housed, there is a strong administrative plan through which the research
potential of the 7 major users with 18 NIH-funded projects and the 10 minor users with 11 NIH-
funded projects will be facilitated and enhanced. Most of the users are from Rush, but we also
have users from 5 nearby institutions including the University of Illinois at Chicago,
Northwestern University, the University of Chicago, Loyola University-Chicago and Marquette
University. The users’ funding comes from 6 NIH Institutes. Several of the users have grants
with significant training components, meaning that the research capabilities at the users’ home
institutions as well as in the field of skeletal biology in general will be enhanced. We have two
prominent experts in hard tissue histology who will serve as consultants. The Advisory
Committee includes Rush and external users. Extensive institutional support is being provided
by Rush University Medical Center. The approaches made possible by this new instrument will
significantly increase the effectiveness and extend the work of multiple NIH-funded
investigators.

Public health relevance
The requested equipment will provide a much-improved means of creating thin sections from tissues containing bone, teeth and various biomaterials for examination in microscopes and other analytic instruments. Current methods for creating these sections have significant limitations, curbing scientific advances. Scientists using this equipment will develop improved understanding of diseases such as osteoporosis, osteoarthritis, rheumatoid arthritis, and osteodystrophy of chronic kidney disease. The equipment will also help to improve our understanding of biological processes underlying bone healing and tissue engineering. This knowledge will be important to improving public health.